Basis and Function of Lateral Assembly of Cadherin Molecules in Adhesive Junctions of Humans and Model Organisms

PROJECT SUMMARY / ABSTRACT
Adherens junctions, desmosomes and endothelial junctions are fundamental adhesive junctions crucial to animal
physiology. Mutations and autoimmune diseases targeting them cause severe disorders in humans. Adherens
junctions are found in all solid tissues and link actin cytoskeletons of adjacent cells, while desmosomes form
strong linkages between intermediate filaments to provide resistance to mechanical stress. Endothelial junctions
are distinct, specialized adherens junctions that maintain the integrity of vessels. Members of the cadherin
superfamily of Ca2+-dependent adhesion receptors form the core transmembrane components of each of these
junctions. Remarkably, our preliminary data show that cadherins of desmosomal and endothelial junctions
spontaneously form highly ordered, intricate junctional architectures between reconstituted membranes through
adhesive trans interactions and putative lateral cis interactions between cadherins on the same membrane. We
have previously characterized their adhesive trans interactions in detail, but the mechanisms by which they
assemble ordered extracellular architectures, including the identity of lateral interfaces, remain unknown. Two
projects in this proposal aim to illuminate this potentially critical, but poorly understood level of structural
organization in molecular detail using a cryo-ET approach in reconstituted and native junctions. At the core of
our approach is a method I developed to overcome the difficulties of studying lateral interactions, which tend to
be weak and poorly detectable outside of a membrane environment. Purified ectodomains are used to
reconstitute junctions on liposomes for direct visualization of assemblies using cryo-ET, providing domain-level
resolution of these large structures and identifying specific interfaces for functional validation by mutagenesis.
We will employ this system to determine the assembly and lateral interactions of vertebrate desmosomal and
endothelial junctions, then extend our findings to native cellular junctions using in situ cryo-ET. Two further
projects investigate how cadherin adhesive and lateral interaction properties translate into function at the level
of tissue organization, integrity and cell sorting using the power of model organism genetics. Direct assessment
of the effects of modifying cadherin properties on morphogenesis in whole organisms has been prevented by
functional redundancy and the high cost, difficulty and time of mouse models. These barriers are overcome in
model organisms, Drosophila and C. elegans, which have highly restricted cadherin repertoires and far superior
genetic tractability. We aim to define the molecular interactions of the adherens junction cadherins of these
model organisms by a combined x-ray crystallography, cryo-EM, cryo-ET and biophysical approach to open up
the use of these facile model systems for structure-function studies testing mutations that modify adhesive
binding specificities, affinities and lateral interactions. Overall, our approach will define a new level of junctional
organization across a range of fundamental adhesive structures and provide a substantial step in our ability to
interrogate the functional effects of cadherin molecular properties on tissue morphogenesis and architecture.

Public health relevance
PROJECT NARRATIVE Intercellular adhesive junctions formed by cadherins are fundamental to development and organization of tissues in all multicellular animals, and their dysfunction in human disease has severe consequences including fatal developmental errors, cancer progression, and skin blistering. At these junctions, cadherin proteins assemble into intricate and highly ordered structures that bridge between the membranes of contacting cells. We propose to investigate the molecular mechanism of how these large and poorly understood superstructures form at critical cell-cell junctions and how they may be changed in disease by using a multi-pronged approach comprising structural, biophysical and functional methods, including direct visualization in cells and native tissues.